An ultra-low-input RNase footprinting assay to quantify cytosolic and mitochondrial translation simultaneously

ABSTRACT
Ribosome profiling isolates ribosome-protected fragments for sequencing and reveals active translation at the
single-nucleotide resolution in vivo. It represents a valuable approach to study various aspects of protein
synthesis, such as the regulation of translation efficiency, alternative translation initiation, ribosome elongation
and pausing, codon usage, and identifying non-canonical open reading frames and micropeptides (<100 amino
acids) encoded in a genome. Thus, it provides unique molecule insights of translational control, which could not
be achieved by other genomic technologies, such as mass spectrometry or polysome profiling. However, current
ribosome profiling protocols generally use complicated experimental procedures to isolate ribosome-RNA
complexes such as though a sucrose cushion, and require millions of input cells. This technical barrier has
prevented its application to examing translation profiles of primary physiological tissue samples with low-input
cell numbers. To tackle this long-standing challenge, here we propose to develop an ultra-low-input RNase
footprinting approach for the rapid quantification of cytosolic and mitochondrial translation simultaneously. Our
method simplified the experimental procedure to select ribosome footprints based on optimized RNase digestion.
My lab has made the assay work well for as few as 1,000 cultured cells. In this proposal, we aim to further
develop the assay and make it work robustly for a small amount of primary tissue samples (Aim 1). Furthermore,
we will apply the method to map the RNA translation landscape of rare progenitor cells and differentiated cell
types during hematopoiesis (Aim 2). The results will reveal novel mechanisms mediating the translational control
underlying hematopoietic cell fate decisions. Finally, by leveraging that our assay provides a simplified method
to study mitochondrial translation, we will use it to examine the heterogeneity of mitochondrial translation
machinery and build the functional network mediated by individual factors (Aim 3). Altogether, the refined ultra-
low-input RNase footprinting method developed in this proposal will be a valuable tool and can be widely used
to study the translational regulation underlying complex physiological conditions from normal development to
disease progression.

Public health relevance
PROJECT NARRATIVE The proposed study is to develop an ultra-low-input RNase footprinting approach for simultaneous quantification of cytosolic and mitochondrial translation. The method will open up an avenue to examining the transcriptomic translation using primary tissue samples for both basic scientific research and clinical prognosis. We will apply it to study the dynamic regulation of translational control during hematopoiesis and build the functional network mediated by mitochondrial translation factors. Our study will lead to novel insights into physiological roles and molecular mechanisms of translational regulation.